FDA FERN Microbiological Cooperative Agreement CP (U18)-NC

PROJECT SUMMARY The North Carolina Department of Agriculture & Consumer Services (NCDA&CS), Food & Drug Protection Division (FDPD) Laboratory is pleased to have the opportunity to submit a proposal for continuation of our FDA FERN Microbiological Cooperative Agreement. We are committed to completing the key project areas outlined in RFD-FD-12-018, including: •participate in FDA/FERN sample analysis •provide surge testing capacity for FDA •use standard methods, equipment platforms and reporting methods •participate in PT programs to confirm competency •participate in FDA and FERN sponsored training •participate in method development, validation and matrix extensions The Laboratory has the infrastructure and personnel in place to accomplish all deliverables set forth by FERN and FDA in this Cooperative Agreement. Through current inspection and surveillance programs, threat agent and foodborne organism analyses, and extensive technical expertise, FDPD can provide added value to our federal partners. Pag 1 o 1

Public health relevance
PROJECT NARRATIVE In the event of a large-scale outbreak or threat incident, FDA laboratories may not have the capacity to accommodate all testing needs. The availability of state laboratories that have the same equipment, test methods and competency as the FDA laboratories is critical to sustaining a large event. The North Carolina Department of Agriculture & Consumer Services (NCDA&CS), Food & Drug Protection Division (FDPD) Laboratory has the capability, capacity and competency to provide surge testing to support a local or national food safety or defense incident. The Laboratory has a strong partnership with FERN, as the Laboratory has been a Cooperative Agreement Laboratory with both FDA and FSIS for several years. We have provided method validation and matrix extension data to the NPO, supplied surge capacity testing when requested, completed surveillance assignments, and been a source of information and expertise to other laboratories within the network. We are an active participant in the FERN community and we will continue these partnerships through this FDA funded Cooperative Agreement. The FDPD is committed to supporting food safety and defense locally and nationally. We have been involved with and support multiple local and national activities and initiatives, including: • Since early 2011, we have been highly involved with FDA and the Partnership for Food Protection initiatives, having representatives on Laboratory subcommittees for the Regulatory Annex, Proficiency Testing, Method Selection, and Accreditation. • NC has a very active Food Safety and Defense Task Force comprised of regulatory (NC Agriculture, NC Public Health, State and Federal FDA), industry, retail, academia. The FDPD Management, Food Program and Laboratory participate in bimonthly state-wide meetings and serve on various committees to develop and implement initiatives for food safety and defense. Laboratory staff is available as subject matter experts. •The FDPD Laboratory is a member of the Association of Public Health Laboratories and participates on quarterly conference calls with APHL and other state agricultural lab representatives. Conference call agendas include sharing ideas and issues for food safety and defense testing. •The Commissioner of the NCDA&CS, Steve Troxler, served as the 2011-12 First Vice- President of the National Association of State Departments of Agriculture (NASDA) and Chair of the Food Regulation and Nutrition Committee, which includes focus on food safety. Commissioner Troxler has been an avid supporter of food safety and defense in NC, sponsoring an annual Commissioner's Food Safety Conferences for 7 years for industry, regulatory, citizen and media education and collaboration on current and emerging issues. The North Carolina Department of Agriculture & Consumer Services (NCDA&CS), Food & Drug Protection Division (FDPD) Laboratory is committed to working with local, state and federal partners in food safety and defense. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Goal The North Carolina Department of Agriculture & Consumer Services, Food & Drug Protection Division (FDPD) goal for this Cooperative Agreement opportunity is to continue to build capability, capacity and competency in the Microbiology Laboratory to support state and national food safety and food defense strategies. Objectives The Laboratory is capable of achieving the three key project areas and additional objectives and requirements outlined in this Cooperative Agreement. • The FDPD Microbiology Laboratory will participate in FDA/FERN sample analysis of surveillance samples, food emergency outbreak samples or large scale surge events. The Laboratory has the capability to test a broad range of samples including fruits (fresh and packaged); juices (concentrate and diluted); grains and grain products; seafood and other fish products; milk and other dairy products; infant formula; baby foods; bottled water; and condiments. • The FDPD Microbiology Laboratory will provide analytical data for potential regulatory use through use of standardized methods, equipment, and reporting methods; participate in proficiency tests and FERN training; maintain a quality management system through maintenance of accreditation to ISO 17025. •The FDPD Microbiology Laboratory will participate in small-scale method development, method validation and matrix extension work as determined by FERN NPO. • The FDPD Microbiology Laboratory has the space, infrastructure, ancillary safety and support equipment to accomplish the goals and objective of this Cooperative Agreement. •FDPD Microbiologists have many years experience in real time PCR, VIDAS, immunomagnetic separation, biochemical analysis and ELISA. •The FDPD Laboratory is accredited to ISO 17025. The Laboratory's quality management system outlines quality assurance and quality control requirements. Processes are in place to monitor sample workflow and reporting. •The FDPD Microbiology Laboratory has, with personnel provide by the Cooperative Agreement, the capacity to analyze 500 samples per year using FERN and FDA BAM methods. •The FDPD Microbiology Laboratory is an eLEXNET Data Transfer partner. •The FDPD Microbiology Laboratory will keep the FERN NPO informed of presumptive positive analytical results.